Translational Research in Biomaterials

ABSTRACT
This application proposes the third renewal of Boston University's NIH training program, Translational Re-
search in Biomaterials (TRB). The TRB mission is to train PhD students as interdisciplinary and transla-
tional research scientists and engineers. The TRB trainees acquire a fundamental and quantitative under-
standing of materials, biomaterial-tissue responses, and molecular and cell biology, as well as interdiscipli-
nary training experiences and education that promote discussion and scientific inquiry in areas outside stu-
dents’ “comfort zones,” such as in business and clinical trials. New for this renewal are the following: a jun-
ior faculty mentoring plan, integrated student governance, better data collection, new courses, professional
development workshops, student founded and led translational MInT program, Fireside chats with key opin-
ion-leaders, peer mentoring program pairing first year trainees with senior trainees, and more targeted ef-
forts for underrepresented minority recruitment.
The cornerstones of the TRB program are the curriculum and the program elements that combine interdis-
ciplinary research, quantitative science, engineering, and translational-based courses in clinical trials and
business, with student-organized seminar club, dinners with clinicians, training in professional ethics, indi-
vidual development plans, and professional workshops/ career panels. Our aim is to teach the unique skills
and competencies that are essential to thrive in a multidisciplinary collaborative team striving to meet com-
mon goals in research, development, translation, and, ultimately, commercialization. Since our initial funding
in 2009, 44 students have participated in the TRB training program: 33 were supported with NIH funds and
11 were co-funded by the BU Departments of Biomedical Engineering and Chemistry. We have accom-
plished our demographic and training mission: 21 women (47%), 23 men (53%), 36% minority, 91% reten-
tion; 100% employment; 22 current students. The TRB trainees have excelled on multiple fronts, including
publications (112 published papers with 57 first-authored; five in review; five in preparation), patent applica-
tions (14), oral (56) and poster (177) conference presentations, competitive individual fellowships (19), and
other awards (27). TRB alumni hold positions ranging from Assistant Professor at Rice University, to a
postdoctoral fellowship at Harvard, to co-founding biomedical start-ups (e.g., Pharmachk). In this renewal,
the continuation of the TRB, with six trainee stipends per year funded via NIH (trainees are supported for
two years) is aligned with the expertise of participating faculty, the availability of a large and strong applicant
pool eligible for and interested in the TRB program (200+ training grant eligible applicants), and an extramu-
ral funding base to provide the appropriate research environment and continued support for NIH trainees
beyond their first two years.

Public health relevance
NARRATIVE Training young scientists and engineers in translational research in biomaterials facilitates the translation of biomaterials-based technologies to the clinic. Specifically, the Translational Research in Biomaterials (TRB) curriculum enables students to develop the creative, analytical, quantitative, and professional skills they need to make new discoveries that will revolutionize fields ranging from diagnostics and drug delivery to tissue engineering. These advances will improve patient care in multiple areas of medicine and ensure an academic and industrial workforce to meet the challenges of the 21st century.